Valacyclovir Phase I Trial

This study, A Phase I Adaptive, Multiple Dose Pharmacokinetic and Safety Assessment of Valacyclovir in
Infants at Risk of Acquiring Neonatal Herpes Simplex Virus Disease, is led by David W. Kimberlin, MD.
Herpes simplex virus (HSV) is a rare cause of disease in neonates, but when it occurs the results frequently
are devastating. Despite important advances over the past thirty years in the treatment of neonatal HSV
disease, significant numbers of babies die or are left with lifelong neurologic sequelae. While the
improvements in outcomes from antiviral interventions have been significant, the best mechanism of averting
death, neurologic damage, and emotional distress from neonatal HSV is to prevent the disease from occurring
in the first place.
Since 85% of babies developing neonatal HSV disease acquire the virus from their mothers during the birth
process, detecting which women are shedding HSV would allow a rational, targeted approach focusing on
those neonates at risk. To accomplish this, however, a simple, standardized, rapid test for detecting HSV in
the maternal genital tract at the time of delivery is required, and a therapeutic intervention that can be used in
neonates exposed to HSV to prevent HSV disease from developing is needed. In a major step toward
accomplishing such an approach, we have completed enrolling an NIH-funded study, in collaboration with
Cepheid Inc., to validate a novel point-of-care polymerase chain reaction (PCR) assay using the company's
Xpert diagnostic platform for the detection of HSV DNA in vaginal swabs of pregnant women at delivery
(ClinicalTrials.gov Identifier NCT01878383).
While this study is an important diagnostic advance, our ultimate goal is to assess whether preemptive antiviral
treatment of babies exposed to HSV at delivery, as detected by Xpert PCR assessment of a maternal vaginal
swab, can prevent HSV exposure at delivery from progressing to neonatal HSV infection and thus to neonatal
HSV disease. To assess this, we will need to conduct a Phase III treatment study in neonates exposed to HSV
at delivery using oral valacyclovir (due to its superior oral bioavailability compared with oral acyclovir). Prior to
this, though, we need to know what dose of valacyclovir administered to neonates safely provides the targeted
acyclovir exposure that we identified previously in babies who already have acquired HSV infection. We
therefore will conduct a Phase I pharmacokinetic study through the Congenital and Perinatal Infections
Consortium (CPIC) to determine the optimal valacyclovir dose and thereby provide trial readiness for the next,
larger efficacy study.